University of Miami kidney Innovative & Interdisciplinary Medical Education in Research Activities (UM-KIIMERA)

Project Summary/Abstract
Nephrology in the United States continues to face substantial difficulties. Interest in nephrology
as a subspeciality has declined amid increased global need while interest in a career as physician
scientist has also fallen. Enactment of programs at earlier stages of training in areas where the
interest is waning should be prioritized. The long-term goal of this renewal proposal is to continue
facilitating interest in nephrology among medical school trainees in Florida and to promote
academic medical research. To achieve these goals, for the past four years we have engaged a
total of 44 first year medical students in a summer program designed to foster interest in
nephrology-related research by exposure to basic, clinical, and translational science research
opportunities. This state-wide summer research rotation in nephrology was entitled UM-KIIMERA:
University of Miami Kidney Innovative & Interdisciplinary Medical Education in Research
Activities. To achieve the dual goal of facilitating interest in Nephrology and academic medicine,
the specific aims of this program remain to: a) Engage ten first year medical students (five from
UM, and 5 from other Florida Institutions) in an eight-week summer research program (b) Retain
the engaged students by promoting their participation in Nephrology scholarly activities, attending
local and national nephrology meetings, and becoming active members of the local APSA
chapter. UM-KIIMERA curriculum has included lectures on clinical, translational and experimental
research, a mentor-mentee lunch, a welcome symposium, an eight week experience in a specific
research project, a “Closing Day” with brief presentations and an introduction to members of the
University of Miami American Physician Scientist Association (APSA) chapter. Several scholarly
activities and research opportunities are provided to maintain the student engaged in the program
throughout medical school. The program is designed to integrate with and facilitate existing
training grants, institutional research opportunities, and research events. An organizing program
committee operates under the supervision of an External Advisory Committee (EAC). A curated
group of CTSI certified mentors will be made available to the students to select for their research
rotation. Outcome metrics collected during the initial cycle were utilized to guide the UM-KIIMERA
2.0 program towards its goals. These outcomes are detailed in the Progress Report portion of this
application.

Public health relevance
Project Narrative There are major issues facing academic nephrology in the United States: the decrease in interest in nephrology as a specialty and the declining interest in a career as physician scientist. Implementation of programs at earlier stages of training in areas where the interest in academic medicine is diminishing is a priority. The goal of this proposal is to continue to engage first year medical students from Florida in a summer program designed to foster interest in basic, clinical, and translational nephrology-oriented research.